Cooperation and antagonism in polymicrobial infection

PROJECT SUMMARY
With the increasing awareness of distinct disease outcomes during polymicrobial infections, there is an urgent
need for mechanistic studies to better define microbial interactions. This application seeks to understand
community interactions between Pseudomonas aeruginosa and Staphylococcus aureus, which are model
organisms to study polymicrobial interactions. They are two of the most common pathogens causing chronic
infections in the lungs of people with cystic fibrosis (CF), medical devices, and wounds, suggesting co-
existence in vivo. Indeed, chronic co-infections caused by these organisms are more problematic than mono-
species infections. However, the relationship between P. aeruginosa and S. aureus is intriguingly complicated.
These organisms often compete in vitro but are frequently co-isolated from the same clinical samples. We
contribute to the studies of anti-S. aureus mechanisms by proposing a novel role for the P. aeruginosa
exopolysaccharide Psl in antagonizing S. aureus growth and interactions with S. aureus protein A (SpA).
Studies proposed in aim 1 will utilize several complementary strategies to define mechanisms underlying P.
aeruginosa Psl-mediated interactions with S. aureus. In aim 2, we will investigate a unique cooperative
behavior associated with P. aeruginosa and S. aureus. This involves production of 2-heptyl-4-hydroxyquinoline
N-oxide (HQNO) by P. aeruginosa, and staphyloxanthin (STX), a yellow pigment synthesized by the S. aureus
crt operon. STX can promote S. aureus resistance to oxidative stress and neutrophil-mediated killing. We
found that STX production in S. aureus, either as surface-grown macrocolonies or planktonic cultures, was
elevated when exposed to sub-lethal concentrations of HQNO. When subjected to hydrogen peroxide, human
neutrophils, or during in vivo infections, P. aeruginosa survival was significantly higher when mixed with wild-
type S. aureus, in comparison to P. aeruginosa cultured alone or with an S. aureus crt mutant deficient in STX
production. Therefore, the focus of aim 2 will be to define the pathways and biological relevance of HQNO-
mediated induction of STX, resulting in resistance to host ROS during infection. Finally, we discovered that a
prior infection of both human- and murine-derived macrophages with S. aureus induces tolerance and prevents
responsiveness to subsequent infection. This is due to significant metabolic rewiring of the macrophage innate
immune response during primary infection. Thus, aim 3 will use primary macrophages and in vivo animal
models to investigate how a S. aureus infection leads to metabolic reprogramming and define how this leads to
epigenetic changes and subsequent innate immune gene silencing. P. aeruginosa and S. aureus interactions
are clearly multifaceted and likely mediated by bacterial factors, spatial distribution during infection, nutrient
availability, and the host microenvironment. These proposed studies will contribute to the understanding of
complex polymicrobial interactions and lay the foundation for strategies to modulate these pathways for better
control of mixed-species infections.

Public health relevance
PROJECT NARRATIVE In this application, we will define mechanisms underlying novel pathways that lead to divergent outcomes during P. aeruginosa and S. aureus interactions. We will also investigate how a prior S. aureus infection of innate immune cells results in a blunted response to secondary infection. The overall hypothesis of this study is that a better mechanistic understanding of antagonistic and cooperative interactions between these two pathogens will lay the foundation for strategies to modulate these pathways for better control of mixed-species infections.